Investigation into the role of lateral hypothalamus GABA and glutamate relative dynamics in encoding affective valence and modulating motivated behaviors

Project Summary/ Abstract
Multiple diseases in humans can be traced to maladaptive reward circuit function including drug addiction,
which costs the United States over 740 billion dollars annually and causes an incalculable amount of human
suffering. Understanding the neural mechanisms that contribute to affective valence and reward behaviors may
facilitate the discovery of therapies to reduce the rate and severity of addiction and other disorders that stem
from reward circuitry. Decades of research demonstrates that the lateral hypothalamus (LHA) is a critical brain
region within the reward circuit. Electrically stimulating the LHA can powerfully reinforce behavior and that
lesioning the LHA reduces motivation across a broad range of behaviors. Recent research into genetically-
defined populations of LHA neurons have found that interspersed populations of LHA cells signal in response
to rewarding events and can produce independent behaviors. Interpreting results in the literature is hindered
due to the fact that experiments into genetically-defined populations of cells have been conducted across
different labs and behavioral procedures. This proposal seeks to determine the signaling dynamics of
multiple LHA subpopulations during emotionally salient events and to determine the casual role of
these signals in mediating reward behavior. During this training period I will learn cutting-edge techniques
including collection and analysis of single cell calcium imaging in behaving mice and causal manipulations of
defined populations of neurons. In Aim 1, we will record the activity of genetically defined populations of LHA
cells during emotionally salient events. These experiments will reveal the signaling dynamics of multiple
populations of LHA cells and will inform our understand of how these populations contribute to reward. In Aim
2, we will determine the role of signaling within these populations in mediating reward behavior. These
experiments will allow us to understand the causal effect of signaling within LHA subpopulations and will
contribute to a theoretical understanding of how the LHA contributes to reward behavior. Altogether, the
results of this project will enhance our understanding of how interspersed populations signal in response to
emotional salient events and how these signals causally shape behavior. The work I will conduct during my
training period will contribute to a greater understanding of neuronal processing of reward may inform future
research into interventions to treat addiction and other diseases of reward circuitry.

Public health relevance
Project Narrative Addiction is a disease, stemming from disrupted processing in neural circuits of reward, that costs the United States over 740 billion dollars annually and causes an incalculable amount of human suffering. This proposal seeks to record neuronal activity of the subpopulations of neurons within the lateral hypothalamus, a key brain region for reward, and determine the causal role of this activity in behavior. This work will contribute to a deeper understanding of neural processing of reward and may assist with designing targeted therapeutic approaches in the treatment of human diseases including addiction.